The BMP-PPARy Axis and Pulmonary Hypertension

Unrepaired DNA damage is a prominent feature of vascular cells in diseases that include pulmonary arterial
hypertension (PAH). During the current grant cycle, we identified a central role for PPARγ1 in DNA damage
sensing and repair that was perturbed in PAH patient pulmonary arterial endothelial cells (PAEC). We
observed that PPARγ forms a complex with the DNA damage sensor Mre11, RAD51 and NBS1 (MRN) and
with the ubiquitin ligase UBR5. We went on to show that this interaction is necessary for the degradation of
ATM interacting protein (ATMIN), thereby permitting phosphorylation of ATM and initiation of the DNA repair
process. In PAH PAEC, high interleukin (IL)6 levels are directly related to the phosphorylation of PPARγ at
serine 245 and its impaired interaction with MRN and UBR5, causing elevated ATMIN and impaired DNA
damage sensing via phosphoATM. In Specific Aim 1, we extend these observations by determining whether
high endogenous IL6 levels phosphorylate PPARγ by activating CDK5 and whether phosphorylation of PPARγ
at serine 245 disrupts its interaction with UBR5 and MRN. We further determine whether this is a function of
loss of BMPR2, the gene mutant in familial PAH and reduced in idiopathic (I) PAH. We also investigate
whether sites of unrepaired DNA damage are associated with specific changes in chromatin accessibility and
gene regulation that impact cell phenotype. We also determine whether reversal of DNA damage in PAH
PAEC, mediated by Nutlin-3-induced p53 and p53-PPARγ dependent genes, restores chromatin accessibility
and gene regulation at sites of DNA damage and thus improves PAEC function. To investigate the relationship
between cultured PAEC and cells in the intact pulmonary arteries (PA) from PAH and control lungs, we
dissociate the cells and incorporate single cell RNA Seq and proximity ligation in situ hybridization (PLISH) on
fixed tissue sections to investigate DNA damage in all cells of the vessel wall as this relates to aberrant gene
expression. In Specific Aim 2, we use two murine models to study the role of DNA damage in the
pathogenesis of pulmonary hypertension (PH). Having shown in mice with EC loss of Bmpr2 that
reoxygenation after hypoxia causes DNA damage and persistent PH that is reversed with Nutlin-3, we will use
single cell RNA Seq to identify gene expression changes that are linked to damaged and repaired DNA. We
will also investigate whether the mouse with DNA damage resulting from loss of ATM in EC has PH, and the
PA gene expression changes involved. In Specific Aim 3, we pursue the DNA damage associated with
phosphoPPARγ in PAH monocytes and determine whether this is a feature of loss of BMPR2 that is associated
with a highly pro-inflammatory pattern of gene expression that can be reversed by roscovitine, the CDK5
inhibitor. Our studies should provide a major inroad into understanding the molecular and functional sequelae
of unrepaired DNA in vascular disease and their potential for reversibility of disease.

Public health relevance
We seek to understand how abnormalities in a cell surface receptor BMPR2 and transcription factors PPAR gamma and p53 make vascular and inflammatory cells vulnerable to DNA damage that leads to the development of pulmonary arterial hypertension. We investigate how the landscape of chromatin accessibility and gene regulation is altered and assess ways in which we can reverse the DNA damage and pulmonary hypertension by restoring normal function of the BMPR2-PPAR gamma axis.